Microanalytics Core

MICROANALYTICS CORE – PROJECT SUMMARY
The goal of the Microanalytics Core is to support the Projects by providing standardized, high-throughput
cryopreserved cell sample thawing, QC, and highly multiplexed multi-omic single cell analysis. To allow for
optimal integration of data across the projects and of experimental batches within the projects, and cost
efficiency, the centralization of these services to the Microanalytics Core, C3, will ensure consistency between
experimental batches and the optimal batch sizes for maximal reagent utilization. The core is led by Andrew J.
Martins, PhD, with Co-Investigators Liza Konnikova, MD PhD, and John S. Tsang, PhD. Drs. Martins and Tsang
have worked extensively together on multi-omics projects with large numbers of human samples, including those
of small samples from children and cord blood samples, and Dr. Konnikova has expertise in utilizing micro-
sampling of blood from neonates for both single cell RNAseq and CyTOF analysis. Dr. Martins will guide core
staff, with input from Drs. Konnikova and Tsang, to provide these services to the projects for maximal utilization
of the project’s precious samples of children and neonates.